RCMI Research Capacity Core

SUMMARY – RESEARCH CAPACITY CORE
The RCMI Cancer and Health Disparities Research Center will enhance the quality and productivity of Xavier’s
basic biomedical, behavioral, and clinical research in the focus area of cancer and health disparities by
establishing a Research Capacity Core (RCC) that will have health informatics and data analytic resources,
shared instrumentation, therapeutic development core facilities, and cell and molecular biology facilities. The
proposed RCC build on the previous Research Infrastructure Core laboratories that served Xavier investigators
and helped enhanced the research capacity in the last U54 cycle. Based on the assessment of strengths and
weaknesses in the current research portfolio of Xavier investigators, the RCC will expand core resources and
implement new rules of prioritization, improved standard operation procedures, and more effective management
of core facilities including convergence of cross disciplinary expertise and cost recovery systems. To maximally
benefit Xavier investigators across all health-related research areas that are being pursued, the RCC proposes
the following specific aims to accomplish the overarching goal of enhancing Xavier’s research competitiveness.
In Aim 1, we will expand and sustain core facilities and resources for Xavier researchers. Addressing Xavier’s
research community needs and challenges, the RCC will expand a Data Science core resource to provide
services in big data analytics, social and behavioral data analysis, bioinformatics and multi-omics analysis,
biostatistics, statistical analysis that can be utilized to address health inequities. The RCC will maintain previously
established core resources including Major Instrumentation facilities, Therapeutic Development resources, and
Cell and Molecular Biology core facilities that have provided essential instrumental and technical support to
Xavier’s biomedical research projects. To sustain these core facilities and resources, the RCC will implement a
stratified and effective cost recovery program and leverage institutional commitment for the maintenance and
operation of the core facilities. In specific aim 2, we will enhance core services in research methodology,
specialized laboratory techniques, statistics, bioinformatics and health informatics. The RCC will expand the
faculty expertise group (FEG) to include two additional data scientists to support behavioral and clinical research
projects. The FEG will consist of senior faculty members with research expertise in experimental design and
research strategy on drug discovery and formulation, cell and molecular biology, mechanistic investigations, and
data processing using various bioinformatics and biostatistics tools, and analytical instrumentation. The
proposed RCC will further prioritize and streamline the services to better meet the needs of Xavier’s research
community. The RCC will have two core directors who will lead the faculty expertise group while also serving as
FEG members. The FEG will be charged with core management, service prioritization, and provision of
consulting services in research methodology development, specialized laboratory techniques, statistics,
bioinformatics and health informatics.